Investigating the Impact of ABL Kinase Signaling on Epigenetic Reprogramming in Metastatic Triple Negative Breast Cancer

Because of its highly metastatic potential and limited treatment options, triple-negative breast
cancer (TNBC) remains a leading cause of cancer associated deaths in women. Recent studies
have shown that distinct chromatin landscapes correspond to metastatic relapse. Our lab has
shown that the Abelson (ABL) family of non-receptor tyrosine kinases promote metastasis of
breast cancer cells through activation of downstream transcriptional changes. However, how
these changes exist in the greater context of global chromatin dynamics has yet to be explored.
My preliminary data suggest that simultaneously targeting the epigenome and the ABL kinase-
regulated transcriptome might be a promising new therapeutic strategy for treating metastatic
triple negative breast cancer. The overall hypothesis of the proposal is that inhibition of ABL
kinases leads to distinct changes in the chromatin landscape that sensitizes TNBC cells to
treatment with drugs targeting epigenetic regulatory proteins leading to TNBC cell death. The
aims of the proposal are to elucidate the epigenetic landscape associated with ABL kinase
signaling to promote metastatic progression, and to understand how these dynamic changes
might be exploited to elicit therapeutic benefit in metastatic TNBC models. Approaches used to
address these objectives will include CRISPR/Cas9 screens, ATAC-seq, and in vitro and in vivo
drug treatment experiments using cell lines and mice respectively.

Public health relevance
Triple-negative breast cancer (TNBC) is one of the leading causes of cancer related death in part due to its highly metastatic potential. Given the contribution of epigenetic processes to metastatic potential, this proposal seeks to tackle the need for effective therapeutic strategies to treat TNBC by interrogating the pathways linking prometastatic tyrosine kinase signaling and the chromatin landscape.